Whole Transcriptome Studies of Blood to Predict Stroke Outcome

Abstract
Several clinical variables are associated with outcomes following ischemic stroke (IS). However, clinical
and demographic parameters account only for a portion of the outcome variance, thus it is difficult for clinicians
to reliably predict long-term IS outcome. Hence, new biomarkers are needed. Molecules in blood are also
associated with IS outcome including pro-inflammatory cytokines, anti-inflammatory cytokines and others.
Genetic risk factors have also been associated with IS outcome. Unfortunately, combined blood and genetic
biomarkers have not improved IS outcome predictions compared to clinical parameters since age, sex and
initial NIHSS is said to predict outcome with a modest c-statistic approaching 0.7. Our preliminary data show
gene expression in blood after IS can predict 90-day outcome better than age, sex and NIHSS. We
hypothesize that a whole-genome approach of measuring RNA, which reflects the genome × environment ×
lifestyle interaction, to assess inflammatory, trophic and clotting genes will improve IS outcome prediction
compared to clinical features alone. Thus, we propose the following aims: Aim #1a. Perform whole-genome
RNA sequencing (RNAseq) of blood on a derivation cohort of IS patients at 1 day and 3 days after IS
compared to matched vascular risk factor controls (VRFC). Aim #1b. Identify the most significantly regulated
genes and pathways in blood at 1d/3d after IS that correlate with outcome, as measured by three outcome
scales – mRS (modified Rankin Scale), NIHSS (NIH Stroke Scale) and Barthel Index at 90 days after IS. Aim
#1c. Use Network Analysis to identify key hub genes after IS associated with outcome that might be causative.
Aim #1d. Use Feature Engineering and Logistic Regression and/or other Machine Learning approaches, such
as Support Vector Machines (SVM) and SVM Regression, to identify the least number of genes at 1 and/or 3
days that predict the three stroke 90-day outcome measures. Aim #1e. In a separate validation cohort of IS
patients perform RNAseq to obtain the expression of the biomarker genes from Aim #1d. Input these into
Machine Learning algorithms to predict patient 90-day outcomes (mRS, NIHSS, Barthel Index). Aim #2a.
Demonstrate that gene expression is a better 90-day outcome predictor compared to each or a combination of
clinical variables, such as stroke volume, initial NIHSS, location, etiology, age, sex, glucose levels, blood
pressure, atrial fibrillation, and neutrophil, monocyte, lymphocyte, and platelet counts. Aim #2b. Delineate the
underlying biology of these clinical outcome contributors by identifying genes and networks that correlate with
them and pinpoint which of the genes/networks also correlate with each of the three outcomes.
Significance: The findings of this study will develop biomarkers of ischemic stroke outcome to help clinicians
predict IS outcome and aid future clinical trials in stratifying IS patients, thus significantly increasing chances
for trial success. Equally important, the findings will provide much needed potential new treatment targets and
unprecedented knowledge of how the peripheral blood transcriptome contributes to outcome and improve our
understanding of the biology of repair and recovery after IS in humans.

Public health relevance
Narrative This project will perform whole-genome RNA sequencing from blood 1 and 3 days after stroke to develop gene profiles using machine learning that predict the outcomes at 90 days after stroke in a derivation cohort; and use the expression of these genes in blood from a separate validation cohort as the input into the same machine learning algorithm to predict 90 day outcomes of the validation cohort with >85% sensitivity and specificity. Gene expression will also be correlated with major clinical variables that are associated with stroke outcome, and utility of clinical variables for prediction of outcome compared to that for the gene expression profiles.